Unlocking the biomedical potential of microbial symbionts from complex ecosystems; Admin Supplement for Instrumentation

Project Summary / Abstract
There is no change, for this section, from the original proposal. Therefore nothing is required here.

Public health relevance
Project Narrative There is no change, for this section, from the original proposal. Therefore nothing is required here.